Project 1: Optimizing a VSV-based virotherapy-based regimen for advanced MM

PROJECT SUMMARY
Oncolytic virotherapy is a two-stage therapy. In the oncolytic phase (short-lived) the infection spreads in the
tumor, killing infected cells and inflaming the microenvironment. In the immune phase (prolonged) priming and
amplification of tumor-specific cytotoxic T cells (CTLs) by inflammatory mediators and phagocytosed debris
from dead or dying tumor cells leads to killing of uninfected tumor cells. VSV-IFNβ-NIS is a fast-replicating
oncolytic Vesicular Stomatitis Virus (VSV) that causes inflammatory tumor cell killing. During the first Myeloma
SPORE funding period, we launched an investigator initiated first-in-human study of single dose, single agent
intravenous (IV) VSV-IFNβ-NIS in patients with hematological malignancies. There is good tolerability and
encouraging signs of antitumor activity. Extensive correlative analyses have been conducted to characterize
the kinetics of the antitumor immune responses, and their relationship to patient-specific baseline parameters.
During the second Myeloma SPORE funding period we seek to maximize the potency of intravenous
VSVIFNβ-NIS therapy by combining (i) repeat virus administration, (ii) early suppression of the antiviral
immune response, and (iii) late boosting of antimyeloma T cells by using a combination of immune suppression
and immune activating regimens with the overall goal to achieve a durable response using VSV virotherapy in
patients with multiple myeloma.

Public health relevance
PROJECT NARRATIVE Live replication competent viruses propagate specifically in tumors, causing cell death and activation of the host immune system to ideally induce long term tumor control. Here, we have engineered a replicating Vesicular Stomatitis Virus to infect tumor cells specifically. The virus has been given by intravenous infusion to patients with myeloma with no safety concerns. In this grant, we propose to combine virotherapy with drugs. The goal is to inhibit the immune system transiently to allow the virus to infect and spread in the tumor, followed by addition of immune enhancing antibody or radiation therapy to enhance overall therapeutic outcome. The timing and sequencing of these immune modulating drugs will be tested in this proposal as well as the safety, and immune responses to the virus and tumor.